Autoantibodies to membrane repair proteins in myositis

Project Summary
Idiopathic inflammatory myopathies (IIM) are a group of inflammatory disorders characterized by muscle
weakness and are associated with significant morbidity and mortality. Inflammation and muscle injury are the
central histology features observed in IIM muscle. Both adaptive and innate immune responses are involved in
the pathogenesis of IIM but the pathogenic mechanisms are not yet well defined. Current treatment options for
myositis are limited and focus largely on the use of broad-spectrum immunosuppressive drugs that often lead to
significant complications. Previous studies with synaptotagmin VII null (SytVII-/-) mice displayed impaired
membrane repair capacity and developed mild myositis at two months of age, suggesting that antigen
presentation of internal skeletal muscle proteins may play a role in initiating or exacerbating myositis. We
generated a more robust model of inflammatory myositis by combining the SytVII-/- model with scurfy mice that
have a regulatory T cell deficiency (FoxP3-/Y/SytVII-/-). Adoptive transfer of lymph node cells from FoxP3-/Y/SytVII-
/- mice into Rag-1-/- mice lacking both T- and B-cells results in significant muscle inflammation. This finding also
links the progression of myositis with defects in plasma membrane repair. The plasma membrane repair
response is a conserved cellular response necessary to restore membrane integrity in myocytes and other cells
as part of normal cellular physiology. Defects in membrane repair are linked to a variety of muscle diseases. Our
previous work helped identify specific intracellular proteins as critical components of the membrane repair
process. This application builds on our recently published work and new preliminary studies that identified novel
autoantibodies in myositis patients against multiple proteins that are essential for the membrane repair. We also
established that these autoantibodies can alter the membrane repair capacity of skeletal muscle. We hypothesize
that compromised membrane repair leads to exposure of these membrane repair proteins to the extracellular
space and that the autoantibodies produced against these proteins further compromise membrane repair and
exacerbate the inflammatory response in myositis. Recent results support this hypothesis as increasing the
levels of the antibodies in a myositis mouse model does elevate the pathologic hallmarks of myositis. We will
test this hypothesis with three specific aims. Aim 1 will define the mechanistic role of autoantibodies against
membrane repair proteins in myositis. Aim 2 will determine if patient autoantibodies directed against membrane
repair proteins are sufficient to induce myositis. Aim 3 will test the efficacy of increasing membrane integrity of
skeletal muscle as a novel therapeutic strategy to treat myositis. Our findings that compromised membrane repair
contributes to the development and/or progression of myositis suggests a potential therapeutic approach for IIM.

Public health relevance
Project Narrative Idiopathic inflammatory myopathies (IIM) such as dermatomyositis are a group of inflammatory disorders characterized by muscle weakness and associated with significant morbidity and mortality with limited treatment options that focus largely on the use of broad-spectrum immunosuppressive drugs with significant complications. Myositis and other IIM represent a truly unmet medical need as there is currently no cure for any IIM. Our research project will test if a new mechanism of muscle cell damage contributes to the progression of myositis and generate proof-of-principle data that increasing the membrane repair capacity of muscle cells may be an effective therapy for the treatment of myositis that does not involve immunosuppression.